Biomimetic Macrophage Membrane-Coated Nanosponges: A Novel Therapeutic for Multidrug-Resistant Pseudomonas aeruginosa and Acinetobacter baumannii Hospital-Associated Pneumonia

PROJECT SUMMARY
Pneumonia is the most common cause of hospitalization due to infection in the US and the most common
cause of infection-related death. Mortality in healthcare-associated pneumonia (HAP) is 13% overall and 36%
in patients admitted to the ICU. Bacterial lung infections are also a frequent complication of prolonged
mechanical ventilation required in patients after major surgery, traume, and severe lung injury due to viral
pneumonias (e.g. SARS-Cov2); mortality in such ventilator-associated pneumonias (VAP) is even more grave.
Two leading bacterial causes of HAP/VAP are the Gram-negative nosocomial pathogens Pseudomonas
aeruginosa (PA) and Acinetobacter baumannii (AB), both frequently highly multidrug-resistant and can develop
resistance to last line carbapenems. Gram-negative bacterial HAP/VAP is frequently complicated by neutrophil-
and cytokine driven hyperinflammation and associated lung damage—which when severe is designated “acute
respiratory distress syndrome” (ARDS). There are no standard clinically proven therapies to support the host
immune system in clearing severe bacterial pneumonia while simultaneously suppressing the
hyperinflammation that leads to lung tissue destruction. Here we describe a highly innovative drug concept for
critically ill patients with severe PA and AB pneumonia with a unique multifold mechanism of action: biomimetic
human macrophage membrane-coated nanoparticles (MΦ-NP). MΦ-NP are made by wrapping cell
membranes derived from human macrophages around biodegradable polymeric cores, retaining their
membrane lipid bilayer and full repertoire of surface structures and receptors, just on a nano (~1/50,000th)
scale. The natural biomimicry imparts to the MΦ-NP the ability to bind, sequester and neutralize bacterial
toxins, lipopolysaccharide (LPS), and host-derived proinflammatory cytokines, a tripartite mechanism of action
to curb harmful inflammation, preserved tissue integrity, and facilitate bacterial clearance. Here we describe our
extensive prior published and preliminary results that strongly support the novel therapeutic concept of MΦ-NP
for the treatment of severe Gram- bacterial pneumonia in ICU patients, and how the proven team at San
Diego-based Cellics Therapeutics will support our Clinical Development Plan at every step of the pathway
toward an investigational new drug (IND) application and entry into Phase 1 clinical trials to meet this critical
unmet medical need. In Aim 1 we will study the capacity of MΦ-NP to preserve lung epithelial and endothelial
barrier integrity and function upon pneumonia challenge, including work in novel 3D human iPSC derived
organoids. In Aim 2, we will examine the ability of MΦ-NP to block excessive alveolar macrophage and
neutrophil-driven inflammation but preserve their antibacterial function against MDR Gram- pathogens. Finally
in Aim 3, we will conduct in vivo analysis of the benefits of intratracheal (IT) and/or intravenous (IV) MΦ-NP
therapy on mortality, bacterial clearance, and lung inflammation/damage in murine models of MDR Gram-
pneumonia and perform key studies to assess PK/PD and toxicity profile of MΦ-NP administration.

Public health relevance
PROJECT NARRATIVE We are investigating a highly innovative therapeutic to counteract detrimental hyperinflammation and lung injury in severe hospital- and ventilator-associated pneumonias caused by the leading multidrug-resistant Gram-negative bacterial pathogens Pseudomonas aeruginosa and Acinetobacter baumannii. Our biocompatible and biodegradable human macrophage membrane-coated nanoparticles (MΦ-NP) neutralize bacterial toxins, LPS, and host-derived pro-inflammatory cytokines to control inflammatory damage and promote effective immune clearance of the pathogens. This novel nanotherapeutic drug concept can reduce one of the most common causes of ICU mortality in the present era of rising antimicrobial resistance.